Project CHOICE: Choosing Healthy Options in Coping with Emotions, a Personalized-Feedback EMA/EMI Study for Emerging Adults Leaving Psychiatric Partial Hospitalization

ABSTRACT
Emerging adulthood represents a common time for problematic mental health issues, particularly affective
disorders such as anxiety and depression, and problematic patterns of alcohol use. Heavy alcohol use can
lead to negative mental health, academic, physical health, and cognitive functioning outcomes. In particular,
individuals who use alcohol are more likely to have psychiatric comorbidity and have poorer clinical outcomes.
Comorbidity is associated with more risk than psychiatric symptomatology or alcohol use alone, yet is
rarely targeted in mental health settings. Using substances for the motive of coping with negative affect
compounds risks, as those who use to cope experience the most problems. As such, it is important to target
alcohol use, particularly in EA with affective disorders who use to cope.
Typical treatment for alcohol is brief, motivationally-based, and provides normative feedback. We propose
to enhance our existing interventions with EA in psychiatric care with affective disorders who use alcohol to
cope, which capitalized on technology. Technology allows for assessment of high-risk situations in real time
through Ecological Momentary Assessment (EMA) and delivery of interventional content by Ecological
Momentary Intervention (EMI). The delivery of tailored, just-in-time risk reduction message paired with
personalized normative feedback may impact problematic use and depression/anxiety outcomes by reducing
the likelihood of use and negative outcomes of use. We propose to enhance our existing pilot intervention by
integrating participant feedback and protocol refinement. In Phase 1, we will (1) make changes to the pilot
PFIcope+EMI, based on participant and researcher experience; (2) evaluate the refined intervention through a
series of focus groups. In Phase 2, we will test our refined intervention (PFIcope+EMI) and in a randomized,
controlled treatment trial as compared to personalized normative feedback only, delivered at baseline (PNF).
The PFIcope+EMI consists of: 1) an in-person personalized feedback session to present normative
information, discuss the individual's use, and generate risk reduction messages to be used in EMI; 2) EMA to
monitor affect, use intention, actual alcohol use, coping motives, and alternate coping skills utilization; and 3)
tailored messages (EMI) based on EMA (i.e., normative feedback plus individualized risk reduction messages
when individuals report negative affect and use intention). The PNF condition will receive 1) an in-person
personalized feedback session to present normative information, discuss the individual's use, delivered at
baseline. We anticipate that this project will lead to the development of a well-specified, novel, technology-
supported, real-time intervention for EA with comorbid alcohol and depression/anxiety that can be later tested
in a multi-site fully-powered RCT.

Public health relevance
NARRATIVE We anticipate that this project will lead to the development of a well-specified, novel, technology-supported just-in-time intervention for emerging adults in a psychiatric partial hospitalization program who use alcohol to cope with negative affect that can be tested in a future fully-powered, multi-site randomized clinical trial. This project will also increase knowledge on the usability, acceptability, feasibility, and effectiveness of the intervention in decreasing rates of use, use and mental health-related problems, and likelihood of substance substitution and of increasing coping skills utilization. If the efficacy of this intervention can be supported, emerging adults with anxiety and depression who use alcohol can be quickly helped.